Hutchinson Center as Lead Academic Participating Site (UG1)

PROJECT SUMMARY
The goal of the NCI National Clinical Trials Network (NCTN) is to develop and conduct state-of-the-art cancer
treatment and advanced imaging clinical trials, especially large, definitive multi-institutional trials evaluating new
cancer therapies and related clinical approaches. NCTN Lead Academic Participating Sites (LAPS) are one
component of this network and will provide scientific leadership in the development and conduct of NCTN clinical
trials in association with one or more adult Network Groups as well as substantial accrual to clinical trials
conducted across the entire NTCN. The Fred Hutchinson Cancer Center (Fred Hutch) is among the nation’s
leading cancer centers and is the only NCI-designated comprehensive cancer research center serving the
WWAMI (Washington, Wyoming, Alaska, Montana and Idaho) region. The broad and deep pre-clinical and
clinical research programs at Fred Hutch supports the NCTN Program in three major ways: (1) The scientific
expertise of the members of Fred Hutch will continue to contribute to the leadership of the NCTN program through
their activities directly at the NCI and in SWOG, NRG and ACRIN. (2) The innovative pre-clinical and clinical
research studies at Fred Hutch will provide the preliminary information necessary to shape the next generation
of cooperative group trials. (3) The large patient base at Fred Hutch combined with expert clinicians and clinical
trials infrastructure will assure substantial accrual to NCTN trials. Fred Hutch and its partners are committed to
the goals of the NCTN and will work to provide leadership for our nation’s clinical trials network.

Public health relevance
PROJECT NARRATIVE In 2023, approximately 1.68 million individuals in the United States will be diagnosed with cancer and almost 601,000 people will die of the disease. Clearly, new approaches to cancer prevention, diagnosis, and treatment are needed and these will only come from new insights achieved through research. As one of the leading cancer research centers in the country, the Fred Hutchinson Cancer Center provides leadership for, and participation in, our nation’s clinical trials network.